Receipt, disparities, and impact of early primary care follow-up after pediatric critical illness

ABSTRACT
Each year in the US, nearly 170,000 children survive critical illness but often face physical, emotional, and
cognitive morbidity following Pediatric Intensive Care Unit (PICU) hospitalization. Despite a rising awareness
that longitudinal evaluation and support may improve post-PICU outcomes, both current and optimal practice
for follow-up after PICU are unclear. Early post-hospital primary care follow-up provides a key opportunity to
evaluate for and address new and ongoing health problems, support continued growth and development, and
assist in the transition back to home and school. As preventative care is a core tenant of pediatric medicine,
some may assume that all children receive timely follow-up after hospitalization, especially after a PICU stay.
However, prior studies show this is not the case. Thus, there is an urgent need for better data to guide the
timing of follow-up after PICU hospitalization discharge. Using national multi-payer data (commercial insurance
& Medicaid), we will measure receipt of early (within 7 days) primary care follow-up after PICU hospitalization
and assess for disparities across patient age, comorbidity status, and socioeconomic status. Secondly, we will
test whether receipt of post-PICU follow-up is associated with reduced 90-day acute care health care utilization
(hospital readmission and emergency department use) using a “target trial emulation”. Target trial emulation
incorporates features of a randomized control trial to provide the best possible causal inference from
observational data. Our specific aims include:
Aim 1: To quantify receipt of early follow-up after PICU hospitalization discharge, and test for variation in the
receipt of early post-PICU follow-up across patient subgroups.
Aim 2: To measure the association between early post-PICU follow-up and acute care utilization among PICU
survivors using a target trial emulation framework.
This proposal is innovative in three key ways—we will answer a novel question using an innovative technique
and data. No studies, to our knowledge, have described the overarching landscape of post-PICU follow up, nor
assessed the impact on subsequent acute health care utilization. We will apply a novel approach to
observational causal inference, “target trial emulation”, which leverages features of randomized control trials to
make causal inferences from observational data. Our findings will provide needed data about whether early
post-PICU follow-up should be standard of care and identify patient groups for whom early follow-up lags. This
work will serve as the foundation for future studies to optimize post-hospital care of PICU survivors—a
vulnerable and growing population of patients.

Public health relevance
NARRATIVE Tens of thousands of children are hospitalized each year with critical illness, many of whom experience physical, emotional, and cognitive problems after hospitalization. Currently, little is known about follow-up practices after pediatric critical illness. The overall objective of this study is to determine how often early post- PICU follow-up occurs, assess whether receipt of early post-PICU follow-up varies across patient subgroups, and test whether early post-PICU follow-up can reduce subsequent hospitalization or emergency department use.